Defining the Translocation Mechanisms of SARS-CoV-2 nsp13 Helicase to Aid in Antiviral Development

Project Summary
SARS-CoV-2, the causative agent of COVID-19, has infected more than 103M people worldwide (February
2021) with more than 2.25M deaths, and represents a dire threat to the health and economic well-being of the
entire world. Although vaccines seem to be effective against SARS-CoV-2, recent information regarding
potential vaccine resistant strains highlights the importance of alternative strategies to combat this virus. The
development of antiviral therapeutics on important mutation resistant viral proteins such as nsp13 is one such
strategy. Improved knowledge of the molecular mechanisms utilized by nsp13 are necessary to rationally
develop inhibitors. This project will address this deficiency utilizing an integrated multiscale modeling, protein
crystallography, and biochemical approach to define how SARS-CoV-2 nsp13 helicase binds RNA and ATP
substrates, transduces energy during ATP binding and hydrolysis, and changes conformation during ligand
binding and catalysis. We propose the following: 1) Identification of molecular-level components of the RNA-
binding and translocation mechanisms of nsp13. Preliminary all-atom molecular dynamics (aaMD) simulations
of SARS-CoV-2 nsp13 have identified key protein-RNA interactions that will inform initial mutagenesis studies.
Further simulation and protein crystallography will inform on the ATP-dependent protein-RNA interactions
observed in the RNA cleft. Biochemical experiments will be performed to test the structure-function
hypotheses generated by the structural-based approaches. 2) Identification of molecular-level features of the
binding, hydrolysis and product release of ATP by nsp13. We have performed aaMD simulations of the SARS-
CoV-2 nsp13 in all relevant substrate states. Soaked-in ATP and non-hydrolysable analogue protein
crystallography will be performed to test these initial models. Subsequent quantum mechanical calculations
will identify key components of the ATP hydrolysis reaction. Site-directed mutagenesis and well-established
enzyme kinetics assays will be used to test effects predicted by these simulations. 3) Identification of allosteric
networks in SARS-CoV-2 nsp13 that transduce energy from ATP binding and hydrolysis to perform RNA
translocation. Utilizing network analyses of aaMD simulations, Motif V has been identified as a key allosteric
contributor. Biochemical studies will be performed to verify that Motif V is necessary for nsp13 helicase
function. Further work will be done to identify allosteric networks between additional components of the ATP
pocket and RNA cleft identified in Aims 2 and 3. This work will produce unprecedented molecular-level insight
into the translocation mechanism of SARS-CoV-2 nsp13 helicases. Key components of this mechanism
represent new targets for antiviral development.

Public health relevance
Project Narrative This proposal seeks to characterize the structural mechanism by which SAS-CoV-2 nsp13 helicase translocates along viral RNA. We hypothesize that ATP hydrolysis couples to RNA translocation through an allosteric network. Our collaborative workflow is uniquely suited to test this hypothesis since we are able to examine the protein from the atomic to virus length-scale. The results from this study will aid in the development of antivirals and guide attenuated vaccine development.